NBER Center for Aging and Health Research

This application is to renew the NBER Center for Aging and Health Research for the next six years, continuing and further enhancing its fundamental role in advancing research on health and aging issues across a large multi-university consortium of economics and multi-disciplinary scholars. The goal of the Center is to stimulate research among new investigators and on new topics in health and aging, systematically advancing science toward the most pressing issues and challenges of an ever-changing societal landscape. The Center will prioritize research development in five thematic subject areas: (1) health and healthcare variation across the population, (2) geography and health, (3) medical innovation and its assessment, (4) applications of artificial intelligence in healthcare, and (5) emerging challenges in long-term care and caregiving. An administrative core will provide intellectual leadership, program management and coordination, meeting planning, and resource management. A program development core will incubate innovative work through pilot projects, as well as mentor early career scientists who are engaged in research on health and aging issues. A dissemination core will publicize the findings of Center research through working papers, academic publications, non-technical articles and reports, including the NBER Bulletin on Health, social media, a website, and conferences. A network core will bring together groups of investigators at different universities and in different disciplinary fields to meet, share ideas and findings, brainstorm, collaborate and plan for the continuing development of their collective research agenda. A particular goal of the continuation is to foster the talents of future and emerging scholars in nearly every Center activity, engaging a next generation of outstanding scientists in the field.

Public health relevance
As an accelerator for cutting-edge science and a fast-track pipeline for emerging scholars and leaders, the NBER Center for Aging and Health Research systematically advances health and aging research toward the most pressing issues and challenges of an ever-changing societal landscape, while supporting new and emerging scholars in the field.